Connecting Alzheimer's Disease to Traumatic Synaptic Neurodegeneration

Alzheimer’s disease (AD) is a global public health crisis with unknown triggers and no disease modifying
therapies. Effective treatments likely must be initiated in the early phases of biological disease, well before
brain reserves of the neural substrates of cognition are depleted leading to overt clinical symptoms. These
‘preclinical’ periods and their triggering events, therefore, are highly significant areas of study. Traumatic brain
injury (TBI), the leading cause of death and disability in younger individuals (under age 45) worldwide, is also
the best-established epigenetic risk factor for AD. Once thought to be a monophasic injury, TBI is now known
to initiate a chronic neuroinflammatory and neurodegenerative process that leads through unknown
pathological mediators to dementing illnesses including AD, ADRDs, and chronic traumatic encephalopathy
(CTE). Synapse loss is a common, early finding in AD, and the strongest pathological correlate of AD-induced
dementia—even stronger than amyloid plaques or tau neurofibrillary tangles. Synaptic injury is also implicated
in TBI in humans and in animal models. Synapses are challenging to study due to their extremely small size and
admixture with the extraordinarily complex subcellular milieu of mammalian neuropil. We developed an
innovative, widely accessible super-resolution imaging and image analysis platform called SEQUIN (Synaptic
Evaluation and QUantification by Imaging Nanostructure) to enable routine monitoring of synaptic health in
animal models and in humans. Our preliminary data demonstrate that delayed cortical synapse loss occurs
after diffuse, closed head, mild TBI in a mouse model, suggesting that synaptic neurodegeneration may lead to
neurological disability following TBI and sensitize the brain to subsequent AD-related synapse loss, hastening
the onset of dementia. We will characterize synaptic neurodegeneration resulting from mild TBI over the
lifespan, and determine its ability to predict neuropsychological and behavioral outcomes. We will then assess
complement activation—a component of the innate immune system that drives synapse loss in AD and is
maladaptively activated after mild TBI— as a mechanism of synaptic neurodegeneration. We will determine
whether targeting the complement pathway can improve synaptic health and improve behavioral outcomes
using genetic and clinically-translatable pharmacological interventions. Finally, we will assess the impact of
mild TBI on synaptic neurodegeneration related to amyloidosis and tauopathy, classic AD-related
neuropathological and biochemical processes. We will determine whether complement inhibition can prevent
TBI-induced potentiation of neurodegeneration in mouse models of these processes. These studies are
expected to reveal intervenable links between early brain injury and long-term neurodegeneration relevant to
the individuals at greater risk of AD and related brain disorders due to an earlier TBI. They will also further
establish innovative synaptic imaging tools (SEQUIN) that will empower routine synaptic analysis in this and
related fields.

Public health relevance
Alzheimer’s disease (AD) is a global public health crisis that specifically impacts the health of synapses, the nodes at which neurons connect to one another to form networks in the brain. Early traumatic brain injury (TBI) is the best-established environmental risk factor for AD, but the structural and mechanistic connections between TBI and AD are largely unknown. This study seeks to characterize synaptic neurodegeneration resulting from TBI and determine its connection to AD, which may help identify new targets for treating neurodegeneration and for preventing acute brain injuries from progressing to dementia.